Benchtop Confocal Microscope

Project summary
This proposal will support the purchase of a confocal microscope for biological research at
Portland State University (PSU). Confocal microscopy is a “magic wand” in the biological
sciences, permitting imaging of cellular and subcellular structures and processes labeled with
exogenous or endogenous fluorophores. The requested instrument is a robust desktop
configuration that does not require a dark room or vibration isolation, making it appropriate for a
broad range of users, including students in courses. The requested configuration has four excitation
lines, four objective lenses including a high-power oil immersion objective, and specialized
software for isosurface rendering, high resolution snapshots, creation of multi-dimensional movies
and downstream image editing. The proposing investigators who will be Major Users have many
years’ experience with advanced light microscopy in both teaching and research, and will use the
instrument in existing funded projects, for new research directions, and for expanding and
developing curriculum. The microscope will serve multiple courses in physics and biology, serving
a broad audience of majors and graduate students across the College of Liberal Arts and Sciences
and the College of Engineering. It will support funded projects on (1) delivery of polyphenols to
cells, (2) the morphology of picocyanobacteria, and (3) anoxia tolerance in killifish. The
instrument will be located in a research corridor serving the Center for Life in Extreme
Environments (CLEE), a PSU Center of Excellence, and as such will be automatically available
to CLEE faculty, students, and external collaborators, currently over 60 faculty, students, and staff
total, as well as to other PSU users and external users. PSU is a minority-serving institution whose
primary mission is undergraduate education; the university currently offers research opportunities
to underserved populations through a number of federal grants. The microscope will be available
to any of these students whose research advisors sign up to use CLEE instrumentation. This
instrument will be the first confocal microscope on campus and dramatically increase research
throughput and quality in the biological sciences, as well as offering opportunities to external users.
It will join several other light microscopes in the CLEE corridor, forming the nucleus of a planned
Light Microscopy Core that will offer training and research opportunities to students and faculty
across campus and to those from other local and regional schools who do not have access to
advanced imaging technologies.

Public health relevance
Project narrative This proposal will support the purchase of a benchtop confocal microscope for teaching and research at Portland State University (PSU). It will be the only modern confocal on campus and dramatically increase research throughput and quality in the biological sciences, support courses in biology and optics, and offer opportunities to users across campus and at other local schools.